ADMIN SUPPLEMENT: DEVELOPMENT OF FUNCTIONAL SPATIAL HEARING IN REVERBERATION

[No Change Proposed by Supplement Activities]
PROJECT SUMMARY/ABSTRACT
Adverse auditory environments in indoor spaces present constant challenges to children during everyday
learning and social interactions. Spatial hearing provides access to auditory cues that promote auditory and
speech perception in these difficult listening situations. However, auditory spatial cues are distorted in most
indoor spaces due to reverberation—the excessive sound energy reflected from room surfaces arriving at the
listener shortly after the initial sound directly from the source. The perceptual consequences of reverberation on
spatial hearing have not been characterized in children with normal hearing, leaving a critical gap in our
knowledge of benchmark abilities to assess hearing device fitting outcomes for children with hearing loss during
real-world listening.
In the proposed work, our goal is to reveal the developmental trajectories of functional spatial hearing abilities
under realistic reverberation between 6- to 18-year-old children. This age range reflects the protracted
development of perceptual abilities, which underlies a multitude of immaturities in children’s processing of
auditory information particularly in difficult listening situations. This work takes an innovative and unprecedented
approach to study the impact of reverberation in auditory virtual reality, in which realistic auditory environments
mimicking children’s learning environments are simulated to maximize ecological validity.
Across the specific aims, we examine three aspects of functional spatial hearing abilities under virtual
reverberant environments that vary in interaural coherence—a metric that describes reverberation severity. In
Aim 1, we will investigate developmental changes in apparent source width—a measure of perceived auditory
object size that is critical for auditory scene analysis. In Aim 2, we will investigate the development of minimum
audible angle, the smallest detectable angular separation between two sounds—a well-tested metric for auditory
spatial acuity. In Aim 3, we will investigate developmental changes in minimum angular separation—a novel
measure of spatial unmasking based on the smallest spatial separation required to receive a target speech
benefit in competing babbles. By correlating the three outcome measures from the independent aims, we will
assess the inter-relationships between auditory object perception, spatial acuity, and spatial unmasking in
reverberant environments among school-aged children.
Findings from the proposed work will (i) establish our understanding of typical developmental trajectories of
functional spatial hearing in realistic reverberant environments, and (ii) elucidate the role of auditory object
perception in spatial acuity and subsequently spatial unmasking in children. Together, this work will provide
intervention benchmark to assess fitting outcomes for children with hearing loss, and will generate substantial
feasibility and pilot data for a planned R01 to develop fitting strategies for children with hearing devices.

Public health relevance
[No Change Proposed by Supplement Activities] PROJECT NARRATIVE The proposed project maps out the developmental trajectories of spatial hearing abilities in complex reverberant environments for school-age children with normal hearing. Findings of this work will provide intervention benchmarks to guide the fitting of bilateral hearing devices (e.g., cochlear implants and hearing aids) for children with hearing loss.